Clinical and Translational Science Institute

Contact PD/PI: Collard, Harold R
OVERALL ABSTRACT
The University of California, San Francisco Clinical and Translational Science Institute (UCSF CTSI) has
a long tradition and strong track record of building infrastructure, securing resources, and fostering and
supporting a diverse, transdisciplinary workforce who share a vision and mission to accelerate research to
improve health. In its second decade, CTSI now proposes a comprehensive plan to advance clinical and
translational research nationally and at UCSF, with seven overall Specific Aims organized around the seven
core themes of the CTSA network: Overall Aim 1. Theme: Methods and processes - Expand CTSI's network of
regional partners to foster team science; improve regulatory efficiency and effectiveness in digital health-enabled
research; implement more robust institutional oversight and stewardship of clinical trials; and strengthen support
for translation of research to practice and policymakers. Overall Aim 2. Theme: Collaboration and engagement
- Fully incorporate community stakeholders into clinical and translational research; promote and catalyze the
translation of research into policy and clinical practice through the development of CTSI's new IMPACT Core;
and expand CTSI's engagement with CTSA network initiatives. Overall Aim 3. Theme: Informatics - Enhance
data interoperability across regional and national CTSA networks; expand informatics support for digital health
research; and develop informatics competencies for the clinical and translational science workforce. Overall
Aim 4. Theme: Integration across the lifespan - Increase integration of special populations into clinical and
translational research; incentivize research across the lifespan through targeted subsidies to investigators; and
collaborate with regional partners serving pediatric and rural populations. Overall Aim 5. Theme: Workforce
development - Develop training programs in clinical informatics and data science; build skills in translating
evidence to policy and practice; and collaborate across CTSA Hubs to enhance workforce development
resources and opportunities for trainees. Overall Aim 6. Theme: Integration of health care and research -
Expand CTSI's engagement in developing a learning health system and bolster CTSI's efforts to translate
research into practice and policy by establishing an institutional home for evidence-to-practice and policy-based
research; Overall Aim 7. Theme: Workforce heterogeneity - Actively develop underrepresented minority trainees
through targeted initiatives and partner with the NIGMS-funded IDeA network to expand CTSI's rural health
impact. These Overall Specific Aims describe a comprehensive strategy for training and sustaining the next
generation of UCSF's clinical and translational workforce, with strategic goals that demonstrate CTSI's
commitment to CTSA's core mission.
Project Summary/Abstract Page 216
Contact PD/PI: Collard, Harold R

Public health relevance
PROJECT NARRATIVE The mission and vision of the University of California, San Francisco's Clinical and Translational Science Institute (CTSI) is to accelerate research to improve health by creating and fostering a transdisciplinary clinical and translational science environment in collaboration with, and embracing the diverse group of scientific and community stakeholders at its center. Integrating core themes of the CTSA network, CTSI will continue to develop, demonstrate, and disseminate innovative research methods and technologies, with a strong and continuing commitment to train and sustain the next generation of clinical and translational scientists, diverse in their disciplines and demographics, and both well-prepared and positioned to lead in this transformative time characterized by the convergence of patient-centered care, digital health, and unprecedented computational power. Project Narrative Page 217